Fluorescent Indicators for Imaging Synaptic Zinc in Cortical Sound Processing

Abstract
Although the importance of synaptic Zn2+, as an emerging neuromodulator throughout the brain, has been widely
appreciated, the dynamics of synaptic Zn2+ release in response to naturally occurring stimuli remains largely
elusive. Genetically encoded Zn2+ indicators (GEZIs) derived from fluorescent proteins are popular tools for
imaging Zn2+ in the cytosol and intracellular organelles. However, fluorescence imaging of Zn2+ secretion in the
brain in live animals has not yet been achieved due to the limitations of current GEZIs (e.g., insufficient
extracellular membrane localization, mismatching affinity, and/or inadequate dynamic range and photostability).
This interdisciplinary multi-PI 4-year R01 project, led by Dr. Huiwang Ai with expertise in genetically encoded
indicators and fluorescence imaging and Dr. Thanos Tzounopoulos with expertise in studying the role of Zn2+ in
auditory processing, aims to (1) develop a new generation of GEZIs to address the hurdles for imaging secreted
Zn2+ in the brain in vivo, and (2) integrate the new GEZIs with our innovative ZnT3 cKO mice, which, for the first
time, allow for Cre-dependent expression of exogenous genes in ZnT3-expressing neurons and Dre-dependent
region- and cell type-specific conditional ZnT3 gene knockout, to identify the cell- and circuit-specificity of Zn2+
dynamics that shape cortical sound processing.
The project will lead to a novel capability of imaging synaptically released Zn2+ in the brain in awake behaving
animals. Our innovative strategy to optimize the exoplasmic location of GEZIs may be generalized to enhance
other genetically encoded indicators. Furthermore, because synaptic Zn2+ is a potent modulator throughout the
cortex, our findings on Zn2+ dynamics in the primary auditory cortex (A1) during sound processing will improve
the understanding of the roles of synaptic Zn2+ in cortical information processing beyond sensory cortices. We
expect our studies to catalyze an extensive array of studies on Zn2+-related neurobiology and neurological
diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Zn2+ has emerged as an essential neuromodulator, and dysregulation of synaptic Zn2+ has been linked to numerous neurological disorders, such as stroke/ischemia, epilepsy, depression, Alzheimer’s disease, and hearing disorders. This project aims to develop new technology for imaging synaptic Zn2+ secretion in awake behaving animals and study the roles of Zn2+ in cortical sound processing. This project will pave the way toward elucidating connections between Zn2+ signaling, information processing, and neurological disorders.